Cellular and Molecular Mechanisms Underlying Neuronal Type-specific Axon Regeneration

Project description
Failure in axon regeneration after nervous system lesion is a major roadblock for
functional recovery. Axon regeneration is controlled by both intrinsic and extrinsic cues
from both neurons and surrounding glial environment. However, our understanding of
glial control of axon regeneration remains incomplete. Here, we investigate axon
regeneration of well-defined sensory neurons in Drosophila larvae. This in vivo model
offers a powerful opportunity to investigate axon regeneration with single-cell resolution
and genetic tractability. Our pilot study has made novel findings by discovering a critical
involvement of glia-neuron interactions, in the form of gliotransmission, in specifying
axon regenerative differences of neuron types. Based on these findings, we hypothesize
that gliotransmission orchestrates neuron type-specific axon regeneration. Specifically,
we propose that axotomy activates Ca2+ signals in glial cells to elicit gliotransmission,
leading to accumulation of extracellular ATP. ATP is then converted by ecto-5’-
nucleotidases to adenosine before activating adenosine receptors in the select neuron
type, resulting in neuron type-specific Ca2+ signals and axon regeneration. In this project,
we will leverage the power of Drosophila genetics and combine it with multidisciplinary
approaches to test this hypothesis. Because axon regeneration mechanisms are
conserved, our findings will likely be relevant to other species including mammals.

Public health relevance
Public health relevance Damage to the nervous system often leads to persistent deficits due to failure of neurons to regrow their axons after nervous system lesion. Axon regeneration is governed by close interactions between extrinsic glial environment and intrinsic growth ability. Investigating how glial control of axon regeneration is of therapeutical significance. In the current proposal, we propose to investigate the cellular and signaling mechanisms by which glial cells control neuronal type- specific axon regeneration in Drosophila, a genetic model organism that shares conserved axon regeneration mechanisms with mammals.